Power Training Combined with Interval Treadmill Training to Improve Walking Activity in Cerebral Palsy

PROJECT SUMMARY/ABSTRACT
Individuals with cerebral palsy (CP) experience a progressive decline in ambulatory ability, beginning in
adolescence and into early adulthood. We propose that impaired muscle power generation is the key limiting
factor affecting walking activity and the ability to physically participate in day to day life. To optimize ambulatory
function, it is also essential to practice the task of walking, known as task-specific training, in order to learn how
to generate muscle power during walking. However, treadmill training for children with CP should be modeled
on the activity pattern of typically developing (TD) youth, which consists of intervals of high intensity activity.
Therefore, the objective of this proposal is to determine the effect of lower extremity Power Training combined
with Interval Treadmill Training (PT3) on functional walking capacity and community-based activity and
participation in children with CP. To identify key muscular mechanisms with this type of training, we will
examine quadriceps muscle performance and architecture. We hypothesize that remediating the most
pronounced muscle performance impairment (i.e., muscle power) with power training combined with a task-
specific approach to walking that is developmentally appropriate will have a significant effect on walking
capacity and performance. This hypothesis will be tested by the following specific aims. Aim #1: determine the
immediate and retention effects of power training combined with interval treadmill training (PT3) on functional
walking capacity in ambulatory children with CP. Forty-eight ambulatory participants with CP (10 to 17yrs) will
be randomized to receive either PT3 or an equivalent dosage of traditional approaches (strength training
combined with traditional treadmill training) for 24 sessions, 3 times per week for 8 weeks. Walking outcomes
will be collected at baseline, immediately post-treatment, and at 2 and 6 months post. Aim #2: quantify the
effects of treatment on in vivo muscle architecture and muscle performance measured with ultrasound imaging
and dynamometry. We hypothesize that muscle power generation is impaired and is responsible for limitations
in walking activity, and that PT3 will result in significant improvements in muscle power that will be explained
partly by increases in cross-sectional area and fascicle length. Aim #3: using coordinate data from global
position system (GPS) combined with accelerometry, we will directly measure the effects of treatment on
community-based walking activity and participation captured in real-world settings. This project is innovative
because it represents a paradigm-shift in current clinical rehabilitation practice in that PT3 targets muscle power
deficits specifically to drive changes in clinic and community-based walking activity that will be measured with
novel technology during day to day life. The proposed research is significant because it will be the first step in
a line of research that is expected to ameliorate the documented deterioration in walking ability that begins in
adolescence and early adulthood in CP. Knowledge generated from this proposal has relevance for the overall
health, mobility, and physical activity in individuals with CP across the life span.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health because the discovery of effective rehabilitation strategies for improving walking activity and community-based participation in youth with cerebral palsy (CP) is expected to mitigate the progressive walking decline in ambulation that begins in adolescence and early adulthood, thus positively impacting quality of life. The proposed research is relevant to the NICHD’s mission pertaining to development of knowledge that ensures the health, productivity, independence, and well-being of people with CP across the lifespan.